The Baboon Genotype-Tissue Expression (GTEx) Project

PROJECT SUMMARY
The baboon (Papio hamadryas) has emerged as a valuable primate model, offering profound insights into human
health, behavior, and evolution. Despite their genetic and physiological resemblance to humans, the availability of
baboon genetic resources, and the complex social dynamics within baboon colonies, population-based functional
genomic studies in baboons and other non-human primates remain limited.
To address this gap, we propose to capitalize on a unique and extensive resource—a large-scale collection of baboon
tissue samples, amassed over a 13-year period at the Southwest National Primate Research Center (SNPRC). This
collection encompasses 51 diverse tissue types, each sampled from at least 60 genetically characterized baboons. Such
a comprehensive baboon tissue collection is unmatched in any other non-human primate species and offers an
unparalleled opportunity for studying gene regulation across multiple tissues.
The goal of this project is to conduct a large-scale, multi-tissue functional genomic study of gene regulation in baboons.
Inspired by the Genotype-Tissue Expression (GTEx) Project in humans, our study aims to generate a comprehensive
catalog of gene expression data derived from dozens of baboon tissues in a large sample of genotyped individuals. By
leveraging bulk and single-cell RNA sequencing technologies, we will acquire transcriptomic data from 60 baboons
across 51 tissues, encompassing vital organs such as the brain, heart, lung, liver, and adipose tissues, among others.
Building upon the comprehensive baboon tissue collection and utilizing advanced genomic techniques, we will map
expression quantitative trait loci (eQTLs) in baboon tissues. Drawing inspiration from the GTEx Project, we will
determine the spatial distribution of eQTLs across genes and regulatory regions, explore patterns of eQTL sharing and
tissue specificity, and disentangle the effects of cell type composition on gene expression by leveraging single-cell
RNA-seq data. We will also investigate potential sex-specific effects on gene expression and cell type composition,
enhancing our understanding of sexually dimorphic gene regulation in baboons.
To maximize the impact and accessibility of our findings, we will develop the Baboon GTEx Portal—an open-access
portal for baboon genomic data. Inspired by the successful human GTEx portal, this interactive website will provide
unrestricted access to baboon data, eQTL information, and other research outcomes. To enable seamless comparisons
with human GTEx data, the portal will incorporate a module for identifying orthologous genes and syntenic regions
between baboons and humans, facilitating comprehensive comparative genomic studies in primates.

Public health relevance
PROJECT NARRATIVE This project aims to leverage a unique and extensive collection of baboon tissue samples to conduct a comprehensive multi-tissue functional genomic study, mapping expression quantitative trait loci (eQTLs) and comparing gene regulation between humans and baboons. By generating valuable insights into gene regulatory differences and developing an open-access portal for baboon genomic data, this research will contribute to the utility of baboons as a model system, increase our understanding of human-specific traits and adaptations, and facilitate comparative genomic studies in primates.